Enterotoxigenic Bacteroides fragilis: A bacterial promoter of colon oncogenesis

DESCRIPTION (provided by applicant): We have identified a human colon anaerobic bacterium, enterotoxigenic Bacteroides fragilis (ETBF), as a candidate etiologic agent for colon cancer and our murine models of ETBF colonization delineate a potential procarcinogenic immune pathway that ETBF induce. Just as the understanding of peptic ulcer disease and ensuing stomach cancer was transformed by the discovery of H. pylori, we hypothesize that ETBF, by secreting the potent B. fragilis toxin (BFT), precipitate procarcinogenic mucosal immune responses, thereby promoting formation of colon cancer. Our model does not propose to alter existing mutational paradigms of colon cancer but rather proposes that ETBF colonization is an integral mechanism accounting for the accumulation of genetic mutations necessary for colon carcinogenesis. This proposal will study the relationship between colon colonization by ETBF in humans, specific colon immune responses and, ultimately, colon cancer. Defining a microbial etiology for colon cancer has key implications as colon cancer is a major public health problem being the second leading cause of cancer death in the United States in women and men. A significant correlation between any two of the studied variables - ETBF colonization, colon immune responses and colon cancer -- will substantively alter current paradigms for the pathogenesis, prevention and therapy of colon cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Colon cancer is the second leading cause of cancer death for women and men. Current approaches to prevention of colon cancer are cumbersome and underutilized due to their expense and inconvenience. This project proposes that colon cancer is triggered by a common stool bacterium called enterotoxigenic Bacteroides fragilis (ETBF) and will test whether detection of ETBF and/or the colon immune response to ETBF provide new, easier approaches to the prevention of the morbidity and mortality due to colon cancer. Colon cancer is the second leading cause of cancer death for women and men. Current approaches to prevention of colon cancer are cumbersome and underutilized due to their expense and inconvenience. This project proposes that colon cancer is triggered by a common stool bacterium called enterotoxigenic Bacteroides fragilis (ETBF) and will test whether detection of ETBF and/or the colon immune response to ETBF provide new, easier approaches to the prevention of the moribidity and mortality due to colon cancer. __SpecificAimsTextDelimiter__ Specific Aims. We have identified a human colon anaerobic bacterium, enterotoxigenic Bacteroides fragilis (ETBF), as a candidate etiologic agent for colon cancer and used a murine model of ETBF colonization to delineate a potential procarcinogenic immune pathway that ETBF induces. Just as the understanding of peptic ulcer disease and ensuing stomach cancer was transformed by the discovery of H. pylori 1, we hypothesize that ETBF, by secreting the potent B. fragilis toxin (BFT), precipitate procarcinogenic mucosal immune responses, thereby promoting formation of colon cancer. Thus, we hypothesize that ETBF represent a key microbial element in the induction of colon cancer and, importantly, define a procarcinogenic immune pathway. Our model (Fig 10, Research Design) does not propose to alter existing mutational paradigms of colon cancer but rather proposes that ETBF colonization is an integral mechanism accounting for the accumulation of genetic mutations necessary for colon carcinogenesis. Defining a human microbial agent precipitating a specific colonic immune response that is carcinogenic has key implications as colon cancer is a major public health problem being the second leading cause of cancer death in the United States. This proposal will study the relationship between colon colonization by ETBF in humans, specific colon immune responses and, ultimately, colon cancer. Solid evidence for this bacterial carcinogenesis model would transform current approaches to the prevention of colon cancer. Both clinical experience and animal models confirm that certain types of inflammatory/immune responses predispose to cancer. Indeed, the two most common inflammatory bowel diseases, ulcerative colitis and Crohn's disease, lead to major increases in the incidence of colon cancer 2. ETBF is an unusual colon bacterium in that it is associated with acute and sometimes chronic inflammatory colitis but also asymptomatically colonizes a significant proportion of humans of all ages 3. It can thus serve as an acute colon pathogen or seem to be a commensal. The major mechanism by which ETBF induces colitis is via secretion of BFT, a metalloprotease toxin with at least 3 isotypes, whose genes were cloned and characterized by the Sears group 4,5. BFT stimulates cleavage of the tumor suppressor protein, E-cadherin, which is one mechanism by which it disrupts colonic barrier function, exposing mucosal and submucosal dendritic cells (key sensors of the immune system) to bacterial products, thereby, dramatically affecting colon homeostasis 6-8. BFT-initiated E-cadherin cleavage activates β-catenin signaling, c-Myc induction, colon epithelial proliferation and mobility as well as inducing NF-κB activation and rapid DNA damage, supporting our hypothesis that ETBF are human oncogenic bacteria promoting colon cancer 9,10. Recent collaborative studies between the Sears and Pardoll groups have demonstrated dramatic enhancement of colon tumor formation in Min (heterozygous Apc mutant) mice colonized with ETBF. Tumor induction occurs, in part, via activation of epithelial and immune cell Stat3 leading to an immune response characterized by IL-17 production by a unique T cell subset, termed Th17. We have now developed a combined approach of real-time PCR, stool culture and serology, optimizing ETBF detection, thereby permitting correlation of low level asymptomatic ETBF colonization with colon cancer. Herein, we will identify ETBF colonization together with BFT isotypes and characterize colon immune responses in patients with colon cancer and controls. A significant correlation between any two of the studied variables - ETBF colonization, colon immune responses and colon cancer -- will substantively alter current paradigms for colon cancer pathogenesis. It will further provide the basis for definitive studies to create new diagnostics and therapeutics for colon cancer. Our specific aims are: 1. To analyze the association of ETBF (together with specific isotypes of BFT) and colon cancer. 2. To identify Stat3 activation in colon cancer and define its association with intratumoral immune responses, particularly Th17 responses. These analyses will be done on 200 colon cancer patients and 200 paired controls matched for age, sex, race and socioeconomic indicators. We will also conduct a nested case control study utilizing the CLUE II repository funded by the NCI to examine for exposure to ETBF and the subsequent development of CRC.